Immunosurveillance and Immunopathology Core

Project Summary
The Immunosurveillance and Immunopathology Core (IIC) by performing mechanistic studies on samples from
the 3 projects of this application will serve a synergistic scientific role with strong emphasis on transplant
tolerance, the central focus of this Program. The IIC will perform assays to analyze the immune alterations in
peripheral circulation, graft and spleen induced by the tolerance regimens proposed in Projects 1, 2 and 3. The
Transplantation Tolerance Laboratory (TTL) has developed a series of Standard Operating Procedures (SOPs)
to analyze the donor-specific immune responses in NHP transplant recipients that will be shared across all the
projects to harmonize the analyses proposed across all the projects in the U19 program. The Core has optimized,
validated, and adopted several cutting-edge technologies and pipelines for bioinformatic data analysis of this
complex dataset across multiple tissue compartments. Comprehensive immune analyses of samples from the 3
projects by the IIC will aid in avoidance of assay and analysis variations resulting in harmonization of results that
will aid in insights obtained in one model to be synergistically deployed across other projects. IIC will perform
assays outlined in the four Specific Aims presented below and conduct bioinformatics and data analysis pipeline
to assess the immune alterations induced by the distinct tolerance regimens utilized in the Projects 1, 2 and 3.
Aim 1: Define the alterations in the immune landscape of renal transplant recipients by high-dimensional CyTOF
profiling of circulating immune cells during induction and maintenance of tolerance. Aim 2: Generate and validate
TCR signatures using single cell TCRseq to track donor-antigen specific CD4+ and CD8+ T cells. Aim 3: Define
the fate and function of donor-antigen specific CD4+ T cells with MHC class II tetramers and single cell ATAC
and RNA sequencing in serial peripheral blood mononuclear cells of tolerant and rejecting renal allograft
recipients. Aim 4: Analyze the spatio-temporal organization of immune cells in renal allografts, spleen, and lymph
nodes at the transcription level by Digital Spatial Profiling and at the protein level by MIBI-TOF. Analysis of
multiple tissue compartments longitudinally to generate a large, but highly controlled, dataset. We intentionally
apply this multi-omics approach to advantage parallel, rather than sequential, discrimination of system level
analyses of immune mechanisms that contribute to transplant tolerance. Analysis of samples from the 3 projects
utilizing distinct tolerance regimens will provide new immunological insights on induction and maintenance of
tolerance. Moreover, the performance of assays across projects supports lateral transfer of knowledge to identify
commonality, independent of strategy, revealing principal features underlying immune tolerance to advance
towards successful clinical application. IIC will interact regularly with the PIs of the 3 Projects and with the
administrative core to design, execute, analyze and trouble shoot the studies proposed in this application.